RACE AND GENER DIFFERENCES IN INTRACEREBRAL AND CAROTID ARTERIAL VELOCITY

Over the past year, doppler ultrasound equipment was purchased for part of the BLSA Vascular Initiative. We are currently recruiting a visiting fellow to carry out the program. We have evaluated the doppler ultrasound equipment to determine how well it should be able to make the needed measurements. The technical accuracy of the equipment appears to be adequate for the planned measurements.